Improving accessibility, accuracy, and efficiency of auditory evoked response testing using a telehealth and artificial intelligence approach

Abstract
Approximately 2 to 3 out of every 1000 newborns in the US experience detectable hearing loss in at least one ear. For
young patients from whom behavioral hearing thresholds cannot be obtained, the neurophysiological potentials evoked
in response to acoustic stimuli, such as the auditory brainstem response (ABR) measured using scalp electrodes, are
often used for hearing diagnosis. Because ABR testing requires specialized equipment and clinical expertise from
experienced pediatric audiologists, there is a general lack of access to diagnostic ABR testing, especially in remote and
rural communities. The overall goal of this project is to develop an efficient automated ABR testing system incorporating
artificial intelligence (AI) to optimize testing for telemedicine applications in hearing screening and diagnostic
applications. An AI-based algorithm that adaptively select the suitable test stimuli during ABR testing, developed at the
University of Washington, will be integrated with a cost-effective hardware platform developed at Intelligent Hearing
Systems Corporation for conducting telehealth-enabled hearing diagnosis. Additionally, the AI-based algorithm will be
further improved using a database of hundreds to thousands of clinical ABR test sessions obtained from Seattle
Children’s Hospital. Two separate data-driven procedures will be conducted. First, the database will be used to improve
the estimation of ABR thresholds, which is the lowest sound level to evoke an observable ABR response and the main
indicator for the degree of hearing loss. It is anticipated that the data-driven procedure in ABR threshold estimation will
improve the performance of the AI-based algorithm, compared to the prototype algorithm that does not incorporate
prior knowledge on ABR data when determining ABR thresholds. Second, a deep-learning model of expert clinicians’
decision-making process will be constructed. The model will take ABR waveform features collected for preceding test
stimuli as its input and predict expert clinicians’ choice for the next test stimulus (for example, to increase the test level,
to decrease the test level, or to repeat the current level). The model will be implemented with AI-based algorithm to
narrow the range for stimulus optimization, hence allowing the AI-based algorithm to make stimulus-selection choice
similar to that of expert pediatric audiologists. It is anticipated that the model of clinicians’ behavior during ABR testing
will improve the efficiency and robustness of the AI-based algorithm. At the completion of the proposed research, a
novel ABR testing system that enables asynchronous tele-diagnostic ABR testing without real-time supervision from an
experienced audiologist will be fully developed and ready for clinical evaluations in the field. Such a system would be
more reliable, efficient, and cost-effective than the synchronous telehealth approach currently available for diagnostic
ABR testing.

Public health relevance
Narrative Approximately 2 to 3 out of every 1000 newborns in the US experience detectable hearing loss in at least one ear. For young patients from whom behavioral hearing thresholds cannot be obtained, auditory brainstem response (ABR) are often used for hearing diagnosis which require specialized equipment and experienced pediatric audiologists. The overall goal of this project is to develop an efficient automated diagnostic ABR testing system incorporating artificial intelligence (AI) for telemedicine applications in order to increase reliable, efficient, cost-effectiveness and provide greater access, especially in rural areas.